Pathways to Resilience of Social Networks of Older Adults with Advanced Cancer

Our study will address the goals of RFA-AG-24-025 by elucidating how the pathways by which key aspects of
social connectedness in social networks (SNs)—structural characteristics, functional aspects, and quality of
relationships—interact and are associated with clinically significant health behaviors of older adults with
advanced cancer. We focus on older adults with advanced cancer with an estimated survival of less than 12
months because our research shows that a) they rely heavily on social networks (SNs) for instrumental and
emotional support, b) their health behaviors are complicated by poor disease understanding, c) aging-related
conditions and treatment-related toxicities adversely affect their quality of life (QoL) and survival, d) their
interpersonal emotional processes and social determinants influence discretionary utilization (e.g.,
chemotherapy) at the end of life (i.e., DIALs), and e) serious illness conversations and advance care planning
with SN members promote appropriate use of palliative care. In this proposal, we focus on three behaviors
known to improve outcomes at the end of life (EoL): initiating and participating in serious illness conversations
about preferences for EoL care, completing advance care planning, and engaging with palliative care. We will
examine how structural characteristics of patients’ SNs (e.g., density; size and composition of inner circle),
their functional aspects for provision of social support, and the quality of relationships (perceptions of
belonging, interpersonal emotional processes) influence these health behaviors. We will also examine SN
resilience: how SNs evolve to continue to provide support for patient behaviors in the face of cancer
progression and network disruptions. We will assess interactions among structure, function, and quality of
relationships of SNs using Mixed Methods Social Network Analysis (MMSNA) to integrate structural analysis
with qualitative assessment of network characteristics, and evaluate associations with health behaviors at the
EoL. At study entry, we will survey 300 patients with advanced cancer (age >65 years, with a life expectancy
<12 months) to assess their SN structures. Then, we will use criterion-based emergent sampling to purposively
select up to 70 patients and one key influential member of their SNs for in-depth semi-structured interviews to
characterize how SN members influence health behaviors of older patients with advanced cancer at the EoL.
Our aims are (1) To assess the interrelationships between SN structure, function, and quality of relationships;
(2) To analyze how SN structure, function, and quality of relationships relate to key health behaviors, including
engagement in serious illness conversations about EoL preferences, advance care planning, and palliative
care; and (3) To describe thematic pathways of network resilience (i.e, how the structure, function, quality of
relationships evolve) in response to cancer progression and SN stressors over 6 months. Our findings will help
develop SN interventions, informed by and adapted to network structures and interpersonal processes of
behavior change, to improve EoL care in older patients with advanced cancer.

Public health relevance
PROJECT NARRATIVE: We propose to address a pressing need to improve quality of life of older adults with advanced cancer by studying how their social networks provide needed instrumental and emotional support and guidance that, in turn, facilitate frank conversations about their illness, advance care planning and engagement with palliative care. While prior studies have examined the structure of social networks (i.e., family, friends, clergy, internet contacts, cancer survivors), ours will be the first to assess how networks function to provide support, and the qualities of interpersonal relationships within the network that facilitate (or impede) behaviors linked to improved quality of life at the end of life. We will use innovative quantitative, qualitative and mixed methods to analyze surveys and network maps of 300 older patients with advanced cancer and in-depth interviews with a diverse subset of 70 patients and their social network members to characterize potentially malleable aspects of structure, function, and quality of relationships that can inform future social network interventions.